Combinatorial engineering of a three-cell synthetic immunotherapy system

Project Summary/Abstract:
T cells, natural killer (NK) cells, and macrophages engineered to express chimeric antigen receptors (CARs)
have shown promise as therapies for cancers, autoimmune diseases, heart disease, aging, and chronic viral
infections. Current therapies use these CAR immune cells in isolation from one another. This contrasts the
natural immune system, which deploys multiple cell types and coordinates their activities to mount immune
responses against pathogens and cancers. A major challenge is to extend our engineering of immune cells to
include co-engineering distinct cell types to function as a synthetic immune system. Such a synthetic immune
system may overcome limitations of the individual CAR immune cell types, provided the cells are engineered
to act synergistically rather than antagonistically. We reason that we can design a three-cell (T-NK-
macrophage) immunotherapy by treating each cell type as a modular part, creating and testing many
combinations of engineered cells. The functions and phenotypes of CAR immune cells can be modulated by
changing the signaling domains of CARs or other receptors such as synthetic cytokine receptors (SCRs). In
this work, we propose to screen CARs and SCR libraries in three-cell immunotherapy systems against
cancer models and to use the screen data to fit dynamical models that describe the time-dependent
behavior of such systems. Using this approach, we will identify CAR-SCR pairs with signaling domains that
tune three-cell immunotherapy function, and create quantitative models to aid in development of new receptors.
In Aim 1, we will construct libraries of CAR-SCR pairs and screen them to engineer a CAR T-NK-macrophage
synthetic immune system with synergistic anti-tumor activity against a leukemia model. In Aim 2, we
will engineer a tri-specific CAR-T-NK-macrophage synthetic immune system to overcome tumor
heterogeneity and antigen escape in the context of a glioblastoma model. To carry out these aims, we will
combine CAR T cells, NK cells, and macrophages and perform in vitro arrayed screens using live-cell imaging,
flow cytometry, and RNAseq to measure immune cell function (proliferation, killing, cell state) and anti-tumor
activity. Dynamical models fit to these data will help us quantify the time evolution of these systems, the activity
of each cell type, and their combined synergy. This work will identify receptors that optimize key anti-tumor
phenotypes of CAR immune cells. This approach will also give us valuable insights into how multiple cell types
synergize or antagonize in the context of a multi-cell therapy. A framework to engineer three-cell synthetic
immune system with receptors that tune the therapeutic functions will facilitate improved therapies for cancers
and autoimmune diseases.

Public health relevance
Project Narrative: We propose to engineer three-cell synthetic immune(therapy) systems in which the activity of chimeric antigen receptor (CAR) T cells, natural killer cells, and macrophages are coordinated for maximum therapeutic efficacy. Arrayed screens and dynamical modeling of hundreds of engineered three-cell immune systems will allow us to identify combinations of receptors that promote therapeutically beneficial cell-cell interactions and synergies. This work will uncover design rules and principals for using engineered immune cells as modular parts that can be rationally combined to create next-generation cell therapies for cancer and autoimmune diseases.